Astrocytic TGFB Signaling Pathways and Neuroinflammation Following Stroke

DESCRIPTION (provided by applicant): Stroke is one of the leading causes of death and disability in the world. The only FDA approved therapy for stroke is tissue plasminogen activator and it is only effective within approximately 4.5 hours following stroke. One promising strategy with a longer treatment window is limiting excessive neuroinflammation following stroke. Excessive inflammation worsens infarct sizes and perpetuates the inflammatory response. Promoting resolution of neuroinflammation after allowing its beneficial effects to occur may improve outcome in stroke. Transforming growth factor betas (TGFβ's) are master regulatory cytokines that are secreted in an inactive form and sequestered in the extracelluar matrix. They are primarily anti-inflammatory and their signaling is elevated days after stroke. Astrocytes are one of the cell types responding to increased levels of TGFβ during this subacute period after stroke. Because astrocytes are glial cells that interact with neurons, blood vessels, and immune cells, they are well situated to coordinate neuroinflammatory responses. However TGFβ's regulation and function in astrocytes is not completely understood. Our preliminary data suggests that thrombospondin-1 production by astrocytes in the stroke border activates TGFβ in the extracellular matrix, and the increase upregulates TGFβ and thrombospondin-1 in astrocytes. Additionally, inhibiting astrocytic TGFβ signaling approximately doubles the inflammatory response, decreases neuroprotective Akt signaling in surviving neurons adjacent to the infarct, and worsens outcomes after stroke. Our central hypothesis is therefore that astrocytes utilize TGFβ in the subacute time period after stroke to trigger a positive feedback loop that leads to higher levels of active TGFβ, which then reduces neuroinflammation and improves outcomes. We aim to determine whether astrocytic TGFβ signaling is necessary and sufficient to trigger a positive feedback loop that increases active TGFβ subacutely after stroke. We also aim to determine whether increasing global or astrocytic TGFβ signaling over baseline is sufficient to decrease neuroinflammation and improve functional outcomes after stroke. To determine whether astrocytic TGFβ signaling is necessary for this positive feedback loop we will use a double transgenic model with reduced TGFβ specifically in astrocytes and supplement this deficit by activating global TGFβ. We will also determine whether this astrocytic TGFβ signaling is sufficient for this positive feedback loop with a different double transgenic model, upregulating astrocytic TGFβ signaling. We will use ELISA, Western blot, immunohistochemistry, and qPCR to measure global levels of TGFβ and thrombospondin-1, and signaling pathways of TGFβ in each of these models. In addition, we will use these models to determine which conditions of TGFβ signaling provide reduced neuroinflammation and improved functional outcomes following stroke. Regardless of our hypothesis being correct, the proposed experiments will provide a better understanding of the mechanisms that astrocytes use to influence neuroinflammation following stroke, which be applicable to other types of central nervous system inflammation as well.

Public health relevance
PUBLIC HEALTH RELEVANCE: Stroke is one of the leading causes of death and disability in the world. There are no effective treatments for the subacute period following stroke. The long-term goal of the proposed research is to develop a treatment to reduce excessive neuroinflammation even if treatment is delayed several days after stroke.